Conduct of studies to evaluate the toxic and carcinogenic potential of alpha-pinene in laboratory animals

The goal of this project is to provide support of the Division of the National Toxicology Program (DNTP) hazard identification activities targeted toward the prevention of diseases or adverse effects caused by environmental exposure to chemical or physical agents. Toxicity testing is an important aspect of public health research in that it serves to identify chemicals that are hazardous to human health. Proper conduct of toxicology studies is required to ensure that the resulting data are reliable. This project involves the conduct of toxicity and carcinogenicity studies of alpha-pinene in rats and mice, with exposure by whole-body inhalation. Alpha-pinene is found in turpentine and in flavorings and fragrances. Humans may be exposed via the air they breathe, through use of personal care and cleaning products as well as in lumber processing and building activities. The data from this project will be used in the development of sound, scientific conclusions about the potential toxicity and carcinogenicity of alpha-pinene in rats and mice and ultimately supports the mission and goals of DNTP and risk assessment activities of other federal agencies. In addition, the public can be adequately informed about risk factors arising from exposure to alpha-pinene. Keywords: toxicity, carcinogenicity, inhalation, alpha-pinene, lung